Antibody and Bioresource

ABSTRACT
The Antibody and BioResource (ABR) Core is a vibrant facility that contributes broadly to the basic
and translational mission of the Center by focusing on two tools central to reproducible research,
specifically antibodies and cell lines. The Core works with researchers to develop new monoclonal antibodies
(MAbs) against their target(s) of interest that will work in the required application(s). MAb developed at MSK are
made available to the scientific community by either sending the hybridoma directly to a researcher or a
company licensed to sell it. To promote the use of healthy cell cultures, an essential component of cell based in
vitro system, the ABR Core offers a mycoplasma testing service. Well authenticated cell lines created at MSK
and deposited into the Core are distributed to researchers and companies around the world, not only ensuring
the tools that the Cancer Center is sharing are of the highest quality buy also helping other reproduce
experiments performed at MSKCC. Relevant information and testing results on curated cell lines are shared
with recipients. These include, but are not limited to, a description and history of the line, references, culture
conditions, unique characteristics, STR profiles for authentication purposes of human cell lines, images of the
cells, confirmation that no mycoplasma was detectable in the culture, karyotyping, and appropriate flow
cytometric analysis.